Mature brain organoid platform for therapeutic screening for ALS/FTD

Abstract
Synapticure is developing a novel patient-derived 3D platform for high-fidelity modeling and screening of TDP-
43 proteinopathy and associated biomarkers for amyotrophic lateral sclerosis (ALS) and frontotemporal dementia
(FTD). Synapticure’s mature brain organoids (mbOrgs) are composed of key neural cells derived from patient-
induced pluripotent stem cells (iPSCs) and are custom assembled into human brain co-cultures, allowing them
to recapitulate several ALS/FTD disease features not seen comprehensively in any existing in vitro models.
Conservatively, 16,000 Americans are affected by ALS, while up to 30,000 suffer from FTD, and the morbidity
and cognitive and physical impairments are significant. Currently, effective diagnostics and treatments for ALS
and FTD are lacking, and newer therapies have translated poorly to humans, despite showing great promise in
in vitro and in vivo preclinical studies. Accurate models of both diseases are critically needed to advance the
development of novel biomarkers, diagnostic/prognostic tools, and therapeutics. Synapticure’s innovative mbOrg
platform answers this need by providing a highly reproducible approach for creating 3D mbOrgs that accurately
reflect disease states relevant to ALS and FTD, including matched pathological features not seen in existing
models. The platform uses an engineering-like approach, where cellular components are generated and
differentiated separately and then assembled into organoids that meet the needs of a specific disease model.
Synapticure has the ability to form mbOrgs from mature human astrocytes (iA) and homogeneous cortical-like
neurons (iN) in defined numbers and ratios, providing a 3D environment with mature astrocytes similar to those
in the healthy human brain and recapitulating key features of ALS such as aging-related disease pathology never
before reported in vitro. Synapticure and our collaborators have recently successfully incorporated iPSC-derived
microglia into mbOrgs, and adding microglia is a priority for this program. Synapticure’s 3D models have been
validated by assaying TDP-43 proteinopathy, which contributes to disease in ~97% of ALS and ~45% of FTD
cases. This includes evaluation of TDP-43 localization and phosphorylation, as well as the mis-splicing of
stathmin-2 (STMN2), a recently characterized biomarker of TDP-43 proteinopathy. Synapticure’s Phase I proof
of concept project seeks to advance a 2D to 3D screening pipeline for identifying such additional compounds
that rescue specific phenotypes via the following Specific Aims:1) Establish and validate a 2D screen showing
TDP-43 proteinopathy and rescue, and 2) Confirm efficacy of therapeutic candidates in 3D by using the 3D
mbOrgs to evaluate the ability of the therapeutic candidates to rescue TDP-43 proteinopathy that is not stress
induced. Following successful completion of this project, in a future Phase II application, Synapticure will look to
expand the platform to patient-derived cells and include other relevant cell types, confirming the ability to screen
compounds against a broad genetic background as a first step towards personalized treatment for ALS/FTD.

Public health relevance
Narrative SynaptiCure’s 3D platform will ultimately enable the: 1) correlation of longitudinal in vitro, disease progression, and outcome data with biomarkers for prognostic value; 2) screening, identification, and validation of disease- specific biomarkers; 3) ability to analyze ALS/FTD patients according to specific variant subtypes; 4) identification and stratification of patient cohorts for clinical trials; and 5) ability to work in partnership with pharmaceutical companies to screen, test, repurpose, and validate novel targeted therapies in patient-derived cell models. This innovation will greatly accelerate the development of novel compounds and advance the use of personalized medicine for ALS/FTD, thus helping to improve the health and quality of life of these patients.